Viral Immunity: Mechanisms and Consequences

ABSTRACT Support is requested for a Keystone Symposia meeting entitled Viral Immunity: Mechanisms and Consequences, organized by Drs. Akiko Iwasaki, Daniel B. Stetson and E. John Wherry. The meeting will be held in Santa Fe, New Mexico from February 19-23, 2017. The primary goal of this conference is to broadly explore aspects of the host-virus interface that are typically treated as separate fields in virology and immunology — fields which often convene their own specialized meetings. The underlying rationale is that each of these fields has matured to the point where the most transformative advances are likely to arise from cross- disciplinary insights, rather than from continued progress in an isolated area. This meeting will foster new interactions and generate new ideas by assembling international experts in the areas of evolutionary perspectives on the host-virus relationship, innate immune detection and control of endogenous and exogenous viruses, memory cell control of viruses at mucosal surfaces, immunological consequences of prior viral exposure, and new approaches to vaccines and therapeutics. Furthermore, the meeting will offer a unique opportunity to bring about the next advances in viral immunity through cross-disciplinary interactions, with the eye towards meeting the NIAID mission of treating and preventing a diverse array of old and emerging viral infections.

Public health relevance
PROJECT NARRATIVE Virus infections remain one of the most prominent threats to global health and economic stability. Recent outbreaks of Ebola and Zika viruses have reminded the public of the threat that viruses pose to humanity. Scientists have been working to understand the dynamics of the host-virus relationship for centuries; the greatest successes including vaccines against viruses like smallpox and polio. However, we have not yet solved the challenges posed by virus such as HIV, hepatitis C virus, and influenza. The Keystone Symposia meeting on Viral Immunity: Mechanisms and Consequences will bring together leading experts in evolution, innate immunity, adaptive immunity, immune memory, chronic infection and vaccine development to gain a clear understanding of the mechanisms of host immunity to virus infection, which will guide efforts to design better treatments for these devastating diseases.